Vision In Nhanes

In 2006 we used the NHANES national survey data to estimate the extent of visual impairment in the United States due to uncorrected refractive error (JAMA 2006;295:2158-2163). We subsequently followed up with an analysis of the cost of refractive correction in the United States realizing that many people already have refractive correction (e.g. eyeglasses or contacts lenses) and others need new or better refractive correction (e.g. a new pair of eyeglasses or a new contact lens prescription) to allow them to see well. Conservatively, the annual direct cost of correcting visual impairment is $4 billion per year, of which $1 billion represents the cost required to provide an initial set of glasses to those in need. In 2008 we investigated, using the NHANES data, the impact of refractive error in Americans ages 12 and older. As an adjunct to these papers, data from the National Health Interview Survey were analyzed to determine the extent of age-related eye diseases and degree of visual impairment reported by American adults. In addition, using focus group discussions, we investigated the factors which influence individuals to seek out preventive eye care services. Our findings indicate that communication between patients and their primary health care providers could facilitate improved access to eye care. In a 2010 analysis of NHANES data on adults over age 40 with diabetes, almost 32% of men and 26% of women, were estimated to have diabetic retinopathy. NHANES retinal data (collected in 2005-2008 with the support of the Centers for Disease Control and Prevention) are also available on the CDCD website making them accessible to the American public, US researchers, and to anyone with web access anywhere in the world. Numerous scientific papers have resulted from analyses of the NHANES data, including deriving estimates on the magnitude and describing the impact of visual impairment due to refractive errors and to eye disease. NHANES data have also been used for surveillance of disparities in vision and eye health. Given the wide array of NHANES data, the eye data has been analyzed in conjunction with non-ocular indicators of health, disease, and functional impairment. Analyses from NHANES have also inspired interest among others to address the global challenge to reduce eye disease and visual impairment and to optimize health for people with multiple chronic conditions. This publicly available dataset continues to be used in peer-reviewed scientific publications. For a list of publications generated with these data, consult PubMed https://www.ncbi.nlm.nih.gov/pubmed/. NHANES data are freely available for public access. See http://www.cdc.gov/nchs/nhanes.htm.